Senior Leadership

The Cancer Center Director, six Associate Directors, and the twelve Program Leaders provide critical leadership for all aspects of the Cancer Center and, along with a select few other institutional leaders, comprise the internal Cancer Center Advisory Committee. Dr. James Downing, the Center's Associate Director for Basic Research, has the important oversight of the Center's Shared Resources. Dr. Victor Santana, the Associate Director for Clinical Research, has oversight responsibility for the clinical trials infrastructure. Due to specialized efforts requiring specific attention, there are also Associate Directors for Administration (overseeing fiscal and administrative aspects of the Center), Cancer Prevention and Control (coordinating the new and extensive efforts to bring epidemiologic and prevention research into the fabric of the center), Outreach (leading efforts in International Outreach and lay education for issues related to childhood cancers), and Training and Education (supporting the recruitment of postdoctoral fellows and organizing didactic training for graduate students and fellows). Each of these Associate Directors has an infrastructure of individuals who report to them and work with them in these capacities to carry out these functions that are vital to the comprehensive functions of the Cancer Center. CCSG funds are requested to partially support the efforts of the Cancer Center Director and Associate Directors for their roles in providing Senior Leadership to the Cancer Center: Kastan, Michael, MD/PhD Program /PI Downing, James, MD Assoc. Director, Basic Research Santana, Victor, MD Assoc. Director, Clinical Research Robison, Leslie, PhD Assoc. Director, Cancer Prev. &Control Ribeiro, Raul, MD Assoc. Director, Outreach Arreola, Mona, PhD Assoc. Director, Administration Chesney, Joan, MD Assoc. Director, Training &Education